Making Healthy Habits Stick: Extended Contact Interventions to Promote Long Term Physical Activity in African American Cancer Survivors

Disparities in cancer survivorship are persistent and pervasive. Obesity, medical comorbidities, second primary
cancers, poor quality of life and compromised physical functioning, disproportionately affect African American
(AA) cancer survivors. There is strong evidence that physical activity (PA) has the potential to eliminate these
disparities. Yet, insufficient PA is more prevalent among AA cancer survivors and 76% do not meet PA
guidelines. Efforts to increase PA longer term in cancer survivors have been modestly successful. The extant
literature and our own preliminary data in cancer survivors shows that PA adoption is often followed by an
attenuation of PA over time. These findings have led to a recent shift in thinking, specifically that the social
cognitive theory constructs (e.g., self-efficacy), important for PA adoption play less of a role in PA
maintenance. Additional theoretical constructs (i.e., habit and identity) may be the key constructs necessary for
long term behavior change. Conceivably, lack of success in promoting PA maintenance may also be due to
few studies examining how well health behavior change interventions work in the broader societal context. For
example, for AAs, discrimination is a potent social determinant of health. Discrimination is prevalent (reported
by 82% of AA breast cancer survivors), disproportionate (AAs are more likely to report discrimination-related
stress compared to other racial and ethnic groups), and stressful (stress, in general, impedes PA). Despite this
evidence, the effect of discrimination on PA intervention outcomes is unknown. Thus, to advance PA
maintenance science with a focus on a vulnerable population, we propose testing two potentially translatable
PA maintenance promotion interventions (Short Message Service [SMS] and peer coach) in 260 physically
inactive AA women cancer survivors using a rigorous, randomized 2 x 2 factorial experimental design.
Survivors will complete a 3-month PA adoption phase (i.e., efficacious theory-based PA behavior change
program) prior to randomization to a PA maintenance promotion intervention or usual care. Our 6-month SMS
and peer coach PA maintenance promotion interventions will be guided by the Multi-Process Action Control
(M-PAC) framework which includes constructs which are understudied in cancer survivors yet hypothesized to
be important for PA maintenance (e.g., habit, identity). Assessments will occur at baseline (pre-PA adoption), 3
months (post-PA adoption; immediately prior to randomization), 9 months, and 15 months. Our specific aims
are: 1) Determine effects of both PA maintenance interventions (SMS, peer coach) compared to usual care on
PA maintenance (i.e., main effects and if either intervention effects differ in the presence of the other); 2)
Identify theory-based mediators of PA maintenance; and 3) Determine if discrimination moderates intervention
effects on PA maintenance. The project will generate new knowledge about the mechanisms underlying PA
maintenance and provide insight about the impact of discrimination on intervention effects thus leading to more
effective behavioral interventions that will improve health outcomes and reduce health disparities.

Public health relevance
Exercising regularly is key to cancer survivors experiencing the health benefits of a physically active lifestyle. This project will evaluate novel interventions designed to assist African American cancer survivors in overcoming exercise barriers, developing a physically active mindset, and establishing exercise habits needed to exercise long term. We will generate new scientific knowledge on the factors most important in helping survivors successfully maintain a physically active lifestyle and gain a better understanding of how discrimination influences the outcomes of interventions promoting physical activity maintenance.